A Disease-Modifying Protein Therapeutic for the Treatment of COPD

PROJECT SUMMARY
Chronic Obstructive Pulmonary Disease (COPD) is the third leading cause of death worldwide at 3.23 million
(2019), while nearly 400 million suffer its effects. COPD is a heterogeneous, multi-phenotypic disease with lung
damage derived from smoking, vaping, cooking, forest fires, pollution, chemical exposure, and numerous
occupational hazards (e.g., 1st responders, military, agricultural and industrial workers). The most common form
of COPD is chronic bronchitis, which is associated with mucus hypersecretion that results in greatly reduced
lung function leading to a decreased quality of life.
Current treatments for COPD largely treat symptoms without meaningfully altering the course of the disease.
There are currently no truly disease-modifying treatments available for COPD patients. Different families
of proteases have been implicated in COPD. Recently, a specific protease has been shown to be upregulated
in lung epithelial cells and macrophages, and its expression in these cells correlates directly with disease severity
in human COPD patients. The target is a pleiotropic membrane bound protein that processes cytokines, growth
factors, receptors, and receptor ligands on the cell surface. Verra Therapeutics has developed a soluble protein
inhibitor, VTH245, that selectively inhibits the proteolytic activity and blocks deleterious activities in models of
COPD. This innovative protein inhibitor has significant advantages in specificity (compared to small molecule
inhibitors), penetration (smaller than monoclonal antibodies), and immunogenicity (based on a naturally
occurring protein sequence). Data generated in our Phase I project have demonstrated that VTH245 treatment
in a gold-standard mouse model of cigarette smoke-induced COPD 1) significantly reduced biomarkers of lung
inflammation and destruction; 2) reduced inflammatory cell counts in the lung lavage to near-air levels; and 3)
reduced mucus hypersecretion. Further, these results matched or exceeded performance of the marketed drug,
roflumilast. While roflumilast treatment is commonly associated with a range of toxicities that limit its use, VTH245
was well tolerated and displayed the highest survival rate over 6-months (20/20 animals). This Phase II SBIR
project will extend our findings from Phase I and provide key IND-enabling safety data to inform future first-in-
human studies through the execution of the following Specific Aims: Aim 1: To identify the preferred route of
administration for VTH245 for treating COPD by comparing the efficacy provided by two clinically relevant
routes of administration, subcutaneous and inhaled, determining a single route for use in toxicity studies in Aim
3; Aim 2: To perform critical CMC activities for VTH245 process development and generate high quality
VT245 for use in toxicity evaluations in Aim 3; and Aim 3: To generate a preliminary safety profile of VTH245
to support IND approval. Successful completion of the Phase II program will further define the target product
profile for VTH245 and provide critical data for an IND submission to support a clinical development program.

Public health relevance
PROJECT NARRATIVE Chronic obstructive pulmonary disease (COPD) is a global, multi-phenotypic disease associated with lung damage from repeated external inflammatory insults such as smoke, vaping, forest fires, pollution, chemical exposure, and occupational hazards faced by 1st responders, the military, agricultural workers etc.. There are currently no treatments available for COPD patients that can halt or reverse the course of this disease. A protein has been identified which is responsible for key clinical outcomes in COPD and Verra Therapeutics aims to leverage this protein as a novel target to dramatically impact lung function in these patients.